PHASE II TRIAL OF RECOMBINANT PEG IL-2 IN PTS WITH COMBINED IMMUNODEFICIENCY

This study set out to restore immunologic competence in selected patients with documented combined immunodeficiency by weekly one-hour IV infusions of PEG rIL-2.